Alcohol Research Consortium in HIV: Administrative Core

This program project application for the Alcohol Research Consortium on HIV (ARCH)* builds
on and extends our very successful administrative and research accomplishments over the past
9 years of NIAAA support. Combining expertise and experience across disciplines and
Universities, the ARCH consortium consists of the Administrative Core (ARCH-AC), the
Biostatistics/Methods Core (ARCH-BMC), the epidemiological research component (ARCH-
ERA) and the implementation research component (ARCH-IRA) and the relapse prevention
research component (ARCH-RPA). The ARCH Administrative Core (ARCH-AC) provides the
infrastructure for oversight, coordination and direction to these program project components,
and facilitates the overarching P01 scientific goals as well as the project aims of ARCH cores
and components. ARCH-AC builds on the administrative structure established during our
previous funding periods, and includes: a Steering Committee (chaired by the ARCH-AC MPIs
and including the Project Leads of the BMC and three research components); Component
Working Committees (chaired by the component Project Lead(s) with participation by
component faculty, staff and mentees, and participation by AC and BMC staff as
appropriate/needed), and the Program Advisory Committee (PAC), an outstanding, already
established board of advisors with national and international expertise in HIV, clinical cohorts,
epidemiology, psychology, implementation research, alcohol use disorder. In addition to
coordinating and documenting a regular meeting schedule across the different committees,
ARCH-AC also uses multiple well-established administrative processes for monitoring project
milestones and quality control, overseeing resource allocation and coordination, ensuring
regulatory compliance, mentoring students and junior faculty, and disseminating new knowledge
through publications, presentations and a project website. ARCH-AC is led by national experts
in alcohol and HIV research and services, who have combined experience in conducting
epidemiologic and clinical research in HIV/AIDS and alcohol use. The ARCH-AC MPIs have
primary responsibility for maintaining communication and collaborative relationships with
external organizations including CNICS, JHU and US CFARs, NIAAA and other program
projects funded under this announcement. ARCH-AC synergizes the proposed epidemiological
and intervention research critical to address NIH and End the HIV Epidemic priorities.